Human mast cell and tissue acquisition core

ABSTRACT
The goals of the human mast cell and tissue acquisition Core B are focused and straightforward: to provide
key services that will be used by all three Projects. Core B will provide well-defined materials to each of these
projects to ensure coordinated methods of approach, and will be available to troubleshoot if problems arise.
Located at the Northwestern University Feinberg School of Medicine under the leadership and supervision of
Dr. Bruce Bochner, Core B will procure, catalog, store and ship de-identified biopsy samples from subjects with
chronic rhinosinusitis, eosinophilic gastrointestinal disorders and atopic dermatitis in collaboration with
physicians and scientists located at Northwestern for use primarily by Project 3. A second important task for
Core B is to generate enriched mature human mast cells derived from tissues such as discarded human skin,
as well as samples of human large intestine and lung resection specimens from the Northwestern Memorial
Hospital for use in in vitro experiments. The third focus of Core B is to assist with and directly generate
“humanized” mast cell mice employing a method by which CD34+ human cells are transplanted into the triple
transgenic NSG-SGM3 (NSGS) mice expressing human IL-3, GM-CSF and SCF. Finally, the fourth
responsibility of Core B is to maintain important human and mouse mast cell lines, and to generate culture-
derived mouse mast cells from bone marrow of mice expressing human Siglecs and from the bone marrow of
the transplanted NSGS mice to generate culture-derived human mast cells, the latter two for use primarily by
Projects 1 and 2. In short, Core B will provide an efficient, standardized and centralized source for mast cells,
humanized mast cell mice, and human tissue specimens. The experience and expertise in isolating and
generating mast cells will be critical to the success of Project 1 and Project 2, while the availability of de-
identified biopsies and discarded surgical tissues from well-characterized cohorts of patients and controls are
essential to the aims of Project 3.